Targeting alternative isoform variation for TCR discovery in platinum-resistant ovarian cancer

PROJECT SUMMARY
We present an interdisciplinary target discovery and T-cell receptor (TCR) therapy development program
focused on platinum-resistant high-grade serous ovarian carcinoma (HGSOC), a highly lethal disease with no
effective long-term treatments or targeted therapies. Nearly all patients diagnosed with HGSOC will relapse after
initial treatment. Disease recurrence within 6 months of platinum treatment is categorized as platinum-resistant
HGSOC, which is highly fatal. Our strategy to develop TCR-based therapies for platinum-resistant ovarian cancer
relies on unmasking the hidden diversity of cancer proteomes produced by RNA dysregulation and mRNA
isoform variation. RNA dysregulation in cancer cells can produce new epitopes through the generation of novel
mRNA and protein isoforms with increased cancer specificity. To identify sufficiently cancer-specific peptide
targets for immunotherapy development, our proposed strategy expands beyond target discovery from somatic
mutations alone. In particular, long-read RNA sequencing (RNA-seq) is a powerful approach for isoform analysis
and tumor antigen discovery. We propose to exploit mRNA isoform variation as a source of shared tumor
antigens for platinum-resistant ovarian cancer. We will first define the landscape of full-length mRNA isoforms in
platinum-resistant ovarian cancer by generating and analyzing long-read nanopore RNA-seq datasets across a
broad cohort of patients with this disease. We will couple this analysis with a big data examination of long- and
short-read transcriptome profiles in a large panel of tumor and normal tissues to assess cancer specificity.
Second, we will directly assay the peptides presented to the immune system by immunopeptidomics, and
examine antigen heterogeneity by single-cell long-read nanopore RNA-seq. Integrating these multiple forms of -
omics analyses with state-of-the-art computational epitope predictions, we will create a highly privileged set of
potential TCR targets. Finally, we will utilize a novel in vitro human artificial thymic organoid (ATO) culture-based
TCR discovery platform to rapidly create and select reactive TCRs from T cells generated through directed
differentiation of pluripotent stem cells. Antigen-specific TCRs will be preclinically evaluated as therapeutically
relevant reagents in vitro and by adoptive TCR-T cell therapy in patient-derived xenograft (PDX) models of
platinum-resistant ovarian cancer. We have assembled a multi-disciplinary team of experts at UCLA and the
Children’s Hospital of Philadelphia, with expertise in ovarian cancer biology and treatment (Memarzadeh), RNA
genomics and computational immuno-oncology (Xing), tumor biology and immunology (Memarzadeh, Seet,
Witte), and T-cell developmental biology (Seet). Our research seeks to discover a new class of antigens and
their cognate TCRs for platinum-resistant ovarian cancer and establish their initial efficacy in preclinical models.

Public health relevance
PROJECT NARRATIVE High-grade serous ovarian carcinoma (HGSOC) is the most common and aggressive subtype of tubo-ovarian cancers. This project will comprehensively elucidate the landscape of alternative mRNA processing and the resulting full-length transcript and protein isoform variation in HGSOC, with the objective of discovering novel immunotherapeutic targets. Our research seeks to find new targets and therapeutic reagents for adoptive T-cell therapy and evaluate their efficacy in pre-clinical models of HGSOC.